Abnormal Bleeding Risk in Female Hemophilia A Carriers

Project Summary/Abstract
This K08 Mentored Clinical Scientist Research Career Development Award application details a 5-year training
program to advance Dr. Cygan’s career goal of developing an independent research program in hemostasis
focused on bleeding tendency in female Hemophilia A carriers. The scientific proposal seeks to investigate
bleeding tendency in Hemophilia A (HA) carriers, which remains largely underrecognized and poorly
understood. HA is due to mutations within the F8 gene encoding coagulation Factor VIII (FVIII), and is
commonly thought to affect only men, while female HA carriers are thought to be only rarely symptomatic.
There are an estimated four female HA carriers for every one HA male, and increasing evidence indicates that
decreased FVIII levels and bleeding symptoms in HA carriers are not rare. Many have significant bleeding
events despite Factor VIII activity levels considered adequate in males. Current understanding of bleeding
tendency in this area is lacking, and research investigating female HA carriers would greatly inform their
classification and management. The proposal seeks to develop a risk prediction model for bleeding tendency in
HA carriers, using parameters other than standard coagulation testing. In Aim 1, a multivariable risk prediction
model will be developed and validated. In Aim 2, a cell culture system to model the HA carrier state will be
developed and the role of X-chromosome inactivation (XCI) in altering basal and stimulated levels of FVIII and
resulting thrombin generation will be evaluated. In Aim 3, the role that natural anticoagulants alter hemostasis
and explain differences in bleeding phenotypes between HA carriers independent of XCI will be investigated.
During the award period, Dr. Cygan will continue to develop his expertise in benign hematology, and further
expand his abilities in experimental design and implementation. A multidisciplinary mentorship team has been
assembled to ensure the success of this project and includes expertise in X chromosome biology, Factor VIII
expression, clinical hematology and biostatistics. The mentorship team includes Dr. Laura Carrel, Dr. Valder R.
Arruda and Dr. M. Elaine Eyster; they will guide Dr. Cygan in meeting his training objectives through direct
research experience, formal didactics, participation in institutional seminars and junior career development
opportunities. Dr. Lan Kong, a biostatistician, will contribute to Dr. Cygan’s research and career plan as a
collaborator and statistical advisor.

Public health relevance
Project Narrative Bleeding symptoms in female Hemophilia A carriers are underrecognized and poorly understood, leading to adverse health events and outcomes. Current methods of assessing bleeding risk in males with Hemophilia A are inadequate when applied to female Hemophilia A carriers, and no formal classification consistent with their bleeding risk exists. To improve the identification and risk stratification of this large group, we will develop and validate a multivariate risk prediction model, perform mechanistic studies to evaluate the underlying molecular basis for bleeding, and evaluate additional modifiers of hemostasis to further refine risk prediction.